Microbial modulation of endocrine signaling in C. elegans

The rising prevalence of metabolic disorders, such as type 2 diabetes (T2D) contribute to kidney, liver, and
cardiovascular diseases, posing a major public health challenge. While poor diet and dysregulated endocrine
signaling are known drivers of these disorders, recent studies underscore the critical role of gut microbiota in
the development of these conditions. Gut microbiota-derived metabolites, including short-chain fatty acids and
secondary bile acids, affect enteroendocrine cells (EECs), which regulate energy balance and glucose
metabolism via the gut-brain axis. Patients with T2D often exhibit gut microbial dysbiosis and an increase in
opportunistic pathogens. Studies have shown that modifying gut microbiota can enhance hormone secretion
from EECs and improve insulin resistance. However, the complex interplay between gut microbiota, host
genetics, and life stages underscores the need to better understand the roles of specific microbes and
endocrine cells within these networks. The invertebrate model organism C. elegans shares highly conserved
physiology with vertebrates, including homologs for insulin and nuclear hormone receptors involved endocrine
regulation of glucose and fatty acid metabolism. In its natural environment, C. elegans interacts with diverse
microbes that impact its behavior and metabolism through key endocrine processes. Research has
demonstrated that microbes influence insulin ligand production, receptor sensitivity, and lipid mobilization in C.
elegans. Thus, the proposed project will utilize C. elegans and the natural microbiome collection (CeMbio) to
investigate microbial regulation of endocrine signaling with depth and breadth: 1) In-depth, the project will map
the genetic circuits connecting commensal bacteria to host endocrine signaling by identifying the
enteroendocrine and neuronal signals involved, pinpointing bacterial metabolites that trigger host responses,
and characterizing the downstream host effectors that regulate gut colonization. 2) In-breadth: the project will
create an open-access database cataloging C. elegans endocrine gene expression in response to individual
CeMbio strains and defined microbial communities. This database will apply machine learning to identify
bacterial functions that regulate host endocrine signaling, serve as a resource for generating new hypotheses
for the research community, and support research training to promote diversity in the STEM workforce. These
efforts will deepen the understanding of how the microbiome influences the gut-brain axis and guide the
development of microbiome-based interventions to improve human health.

Public health relevance
PROJECT NARRATIVE This project seeks to investigate how gut microbiota influences endocrine signaling pathways and metabolic regulation using C. elegans as a model system. By identifying bacterial metabolites and genetic circuits that affect host endocrine responses, this research aims to uncover the mechanisms driving microbial contributions to metabolic disorders, such as type 2 diabetes. The findings will inform the development of microbiome-based interventions to improve metabolic health and prevent related diseases.